Cancer Biology Program

The Virginia Commonwealth University (VCU) Massey Cancer Center (MCC) created the new Cancer Biology (CB) program in 2020 by merging the former Cancer Cell Signaling and Cancer Molecular Genetics programs. The overreaching goal of this restructuration is to build a robust transdisciplinary scientific environment that enhances collaborative interactions among all MCC members and provide increased opportunities to leverage new scientific concepts with the potential to deliver groundbreaking therapeutic approaches to curb all human malignancies. To achieve these objectives, the CB program created 3 specific aims that encompass the vast majority of research areas being pursued within the MCC catchment area and across Virginia Commonwealth University (VCU) in general.

Public health relevance
Through these complementary and overlapping specific aims, we intend to unravel the mechanistic underpinnings of tumor pathogenesis and progression and to identify key interactions between tumors and their microenvironment that could shed light on the intrinsic and extrinsic mechanisms accounting for cancer progression. Achieving a greater understanding of the complex facets of cancer biology will be instrumental to developing innovative and highly efficient therapeutic tools that could be utilized to target simultaneously disease components in a patient-specific manner to maximize therapeutic response, mitigate drug toxicities, and combat the development of resistance. Notably, many CB program studies rely heavily on multiple shared resources, including the Transgenic/Knockout Mouse Shared Resource (TG-KO), Microscopy Shared Resources (MSR), Flow Cytometry Shared Resource (FCSR), Cancer Mouse Models Core (CMMC), and Biostatistics Shared Resource (BSR).